FOOD HYPERSENSITIVITY IN THE PATHOGENESIS OF ATOPIC DISORDERS

The purpose of this study is to delineate the involvement of IgE-mediated hypersensitivity in atopic dermatitis, asthma, and adverse reactions to food.